Enhancing Diversity in the Summer Program in Neuroscience at Boston University

ABSTRACT
The Summer Program in Neuroscience (SPIN) at Boston University School of Medicine is a unique, annual 8-
week program in which 10–15 undergraduate students perform mentored neuroscience research, receive
instruction in graduate-/medical-level neuroscience, and observe clinical activities focused on the diagnosis and
treatment of brain disorders. In the classroom, students meet with decorated medical school teaching faculty
and learn basic and clinical neuroscience through small-group interactive sessions, analysis of clinical and
research problems and cases, analysis of brain structure using microscopic brain sections and magnetic
resonance imaging (MRI) brain scans, as well as hands-on exploration and dissection of human brains. For the
research portion of the program, students are paired with a faculty member from a basic science or clinical
department and conduct a mentored research project, the results of which are presented at a public conference
that closes the session. In the clinic, students rotate on neurology and neurosurgery inpatient and outpatient
services, attend brain cuttings sessions in the hospital morgue, and review radiographic studies with working
neuroradiologists. These three aspects of the program intersect to generate a nuanced education in the structure
and function of the brain in health and disease from both research and clinical perspectives. To help participants
integrate SPIN experiences with their future, sessions are held that focus on scientific skills and career
development, including sessions on applying to graduate and medical schools, developing oral presentation
skills, and interview skills. End-of-program interviews with prior participants indicate students felt that SPIN was
a life-changing experience that encouraged and helped them pursue further graduate and medical education.
Although we have made every attempt to recruit students from traditionally underrepresented minority
backgrounds, the tuition-based model of our program has been a significant barrier. As a result, SPIN participants
have lacked the diversity that characterize the ideal clinical and research teams. Funding from this proposal
would subsidize the cost of participating in the program (tuition and housing) and provide stipend support for six
scholarships. We will target recruitment to outstanding underrepresented minority students in institutions and
biomedical conferences historically attended by these students, and restructure our application and our
admittance for tuition-based students to place an emphasis on accepting students who have demonstrated
commitment to diversity. We also propose to change the program to target specific scientific skills and expand
programming of career development. Finally, we will implement a thorough real-time tracking and evaluation
plan to follow our students and measure the impact of the program on their career choices through the
establishment of digitally-based interactions and communities. The goal of this proposal is to provide talented
students from underrepresented populations with access to formative experiences and training that will guide
them toward successful biomedical careers and thus diversify the biomedical workforce.

Public health relevance
NARRATIVE The goal of this proposal is to provide talented students from underrepresented populations formative experiences and training that will contribute to their scientific development and guide them towards successful careers in the biomedical workforce. To achieve this goal, we will recruit outstanding underrepresented minority students and subsidize their tuition, wages, and housing costs for the Summer Program in Neuroscience (SPIN) at Boston University School of Medicine, an existing summer program that integrates mentored neuroscience research with small group graduate-and medical level neuroscience education, and exposure to clinical activities focused on the diagnosis and treatment of brain disease. Graduates of our program have mentioned it has been a life changing experience that has motivated them to pursue careers in science and medicine; we expect that SPIN will provide positive and motivating experiences for underrepresented minority students, and help to increase the numbers of underrepresented minorities in the biomedical workforce.